Risk Environments of Permanent Supportive Housing for Formerly Incarcerated People with Serious Mental Illnesses

ABSTRACT
Formerly incarcerated people with serious mental illnesses (SMI) experience the criminal legal system
unequally and have elevated rates of recidivism, homelessness, general medical problems, and substance use
disorders. Permanent supportive housing (PSH) is a housing intervention often used during reentry, but it has
limited resources for addressing community integration, a key component of reentry. PSH are often located in
high-poverty environments with increased criminogenic risk. The geography of PSH also includes public spaces,
which are associated with greater self-esteem, life satisfaction, a positive orientation toward recovery,
independent employment, and access to tangible and social resources. The risk environment framework
provides a structure for understanding the geography of PSH through its focus on the physical, social, economic,
and policy influences on both the micro and macro environments. During reentry, individual, interpersonal, and
environmental factors can interact with these environments to produce or reduce risk. If addressed, these factors
can contribute to reentry wellbeing, through improved community participation and treatment engagement and
reduced psychiatric distress and substance use, ultimately supporting more targeted interventions.
The proposed study uses a rigorous nontraditional QUAL + QUAN (spatial) concurrent mixed-methods design
to examine how individual, interpersonal, and environmental factors situated in the risk environments of PSH
interact with public and private spaces to inform reentry wellbeing. Eighty multi-method interviews (i.e.,
qualitative, quantitative, and participatory mapping methods) that look at individual, interpersonal, and
environmental reentry factors will be conducted with formerly incarcerated clients with SMI. Data collected will
be triangulated with go-along interviews with up to 20 of the participants. Participatory mapping will then be
geocoded and sites identified as places of importance, frequent participation, and belonging will be evaluated in
relation to objective features of spaces like resource and treatment availability or accessibility using GIS methods
in order to develop a community resilience index model. A cluster analysis will additionally be conducted to
identify and map areas of increased and decreased drug overdose and arrest and overlaid with the community
resilience index model to examine the relationship between community resilience and the risk environments. I
will then partner with a community advisory board of 2 providers and 6 formerly incarcerated PSH residents to
integrate the findings for the purpose of co-designing a targeted multilevel intervention aimed at improving
reentry wellbeing through public space engagement. My proposed research plan integrates activities, formal
training, and mentorship from experts (Drs. Michael McDonell, Benjamin Henwood, Ofer Amram, Chyrell
Bellamy, Susan Collins, and Mark Salzer) in supportive housing, the risk environment framework, spatial
analysis, intervention development, community-based participatory research, and the mental health and criminal
legal systems. The Mentored Research Scientist Development Award (K01) will build on my previous training
and research to allow me to pursue my long-term career goal to become an independent investigator focused
on the use and interaction of public and private spaces in supporting reentry from prisons and jails for people
with SMI.

Public health relevance
PROJECT NARRATIVE While permanent supportive housing is typically situated in high-risk environments, it is also surrounded by public spaces that can be resourceful and supportive for formerly incarcerated people with serious mental illnesses. The risk environment framework provides a structure for understanding the geography of permanent supportive housing during reentry, including the individual, interpersonal, and environmental factors interacting with these spaces to reduce risk and promote reentry wellbeing. This project involves career development and training activities that will enhance the applicant’s expertise in spatial methods supportive housing and the risk environment framework, community-based intervention development, and community-based participatory research methods to help support the use and interaction of public and private spaces in supporting reentry from prison for people with serious mental illnesses.